Engineering next generation supercharged CAR T-cells against solid tumors

Project summary
Adoptive cell therapy has revolutionized cancer treatment and has immense potential to cure a variety of cancer
types. Multiple critical barriers exist for current CAR-T therapy particularly in solid tumor, including insufficient T
cells trafficking to the cancer site, lack of effective cancer cell killing, severe toxicity, strong immunosuppression
in the tumor microenvironment, and lack of persistence. Overcoming these barriers is critical to achieve the full
potential of CAR-T. To overcome these challenges, it is important to identify gene targets that can boost multiple
features of T cells function, especially from fully unbiased genetic screens performed in primary T cells. We have
recently developed such T cell CRISPR-based screening approaches. These genetic screens, coupled with
stringent selection of T cells for properties – including enhanced potency, persistence and in vivo
infiltration/activity – have identified gene modifications that maximally enhance desired T cell properties.
We conducted knock-out and gain of function in vitro and in vivo CRISPR screening in primary T cells and
identified multiple novel negative/positive regulators of T cell function, in animal tumor models using different
CAR-Ts (e.g. CD19, CD22 and HER-2 CARs). We identified two especially potent gene modifications that
augment CART-Ts: 1) PRODH2 overexpression resulting in metabolic boost and 2) PRDM1 (exon 3) deletion
resulting in epigenetic modulation. This initial research and methods pave the way for further enhancements.
Our central hypothesis is that engineering CAR-T cells with a metabolic boost from PRODH2 overexpression
as well as epigenetic regulation by PRDM exon3 deletion can enhance HER2 CAR-T cell performance and
enhance anti-tumor efficacy in vivo. To do this, we will utilize our knock-in/knock-out (KIKO) protocol to introduce
CAR and gene modification sequences precisely at the TRAC locus to generate four HER2 CAR-Ts: PRODH2-
OE, PRDM1-KO, PRODH2-OE+PRDM1-KO and control CAR-T. The in vitro characterization (level of CAR
expression, proliferation, immune phenotyping, serial killing ability) as well as in vivo evaluations (efficacy, CAR-
T infiltration and persistence) of each of the 4 CAR-Ts will be performed using at least two cancer cell
lines/mouse model. Our vector and manufacturing processes in this proposal are identical to the planned GMP
clinical approach, allowing smooth transition to clinical development.
If successful, this study will identify our best performing HER2 CART and provide sufficient data to support a
Phase II SBIR submission, and allow a path towards an IND and first-in-human Phase 1 clinical trial, thus
delivering a superior CAR-T candidate for patients with solid tumors. In broad terms, the major goal of this study
is to evaluate if metabolic boost and epigenetic reprograming when combined result in more effective CAR-Ts
relative to either modification alone.

Public health relevance
Project narrative Cell therapy such as CAR-T is a revolutionary type of cancer treatment with the immense potential, however, multiple critical barriers exist for current cell therapy. We will use our novel well-established engineering approach to create a novel and superior CAR-T against HER-2. Our project will determine our best performing HER2 CART, providing sufficient data to support a Phase II SBIR submission for future clinical translational work and a path towards an IND and first-in-human Phase 1 clinical trial.